Precision Assessment Algorithm for Reducing Disaster-related Respiratory Health Disparities

ABSTRACT
Weather and climate disasters are responsible for over 13,000 deaths and $1.7 trillion additional costs over the
last 40 years in the USA. Older adults are particularly susceptible to respiratory symptoms, disease
exacerbation, unscheduled health care utilization, and decreased quality of life after disaster exposure to
particulates, mold, and flooding. Our preliminary data reveal those with Black racial identities possess fewer
resources to prepare for disaster. Profound racial disparities observed in the COVID-19 pandemic illustrate the
devastating sequelae of long-standing macro-level disparities of segregated housing and sociopolitical
networks. The long-term goal of this work is to eliminate racial disparities in large scale disaster health
outcomes. The short-term goal of this research is to identify pathways of equal opportunity and disaster
affirmative action interventions. The objective here is to create a software prototype of a machine learning
algorithm with a novel, valid and reliable assessment tool of disaster vulnerability for older adults with chronic
obstructive respiratory disease, prioritizing equality of opportunity to reduce racial bias and disparity. Our
specific aims are to 1) Empirically validate a novel assessment tool of disaster vulnerability using self-reported
items and scoring system, 2) Refine the validated instrument with a machine learning based algorithm for
precision prediction of household emergency preparedness for disaster, 3) Assess racial disparities, data and
algorithm bias for Black participants in household hazard vulnerabilities and our instrument development
process, and 4) Test interoperability with existing customer software platforms as a plug-in software add-on.
We will accomplish these aims using a mixed-methods approach, recruiting 20 expert panel members and up
to 600 potential end-user participants, working to over-sample those who reside in predominantly Black
communities and Black racial identities. The knowledge gained from this study will provide foundational work to
develop precision interventions to reduce post-disaster respiratory symptoms, disease exacerbation,
unscheduled health care utilization, and decrements in respiratory quality of life. The results of this study will
inform the next generation of electronic health record and patient reported outcomes applications, ensuring the
validity, prognostic accuracy, and machine learning models are most relevant to those at highest risk for racial
disparities: those with Black racial identities. Health care providers can use our software tool to target and
optimize disaster telehealth service lines and increase intervention precision to reduce disaster morbidity and
mortality disparities.

Public health relevance
Our goal is to identify pathways of equal opportunity or precision affirmative action interventions to eliminate racial disparities in large scale disaster health outcomes. Here, we propose to create a software prototype of a machine learning algorithm with a valid and reliable measure to score household occupant disaster vulnerability for older adults with chronic obstructive respiratory disease, prioritizing mathematical modeling of equality of opportunity to reduce racial bias and disparity. Collecting and analyzing both qualitative and quantitative data, we aim to: 1) validate a novel assessment instrument, 2) test the instrument for precision prediction of household emergency preparedness for disaster, 3) assess racial disparities, data and algorithm bias for those with Black racial identities, and 4) test the interoperability of our novel software prototype with existing electronic health record platforms.